A community intervention to promote evidence-based mental health care for olderadults with depressive and anxiety symptoms.

PROJECT SUMMARY/ABSTRACT
This is an application to the K43 Fogarty Emerging Global Leader Award for Oscar Flores-Flores, MD, MSc.
Dr. Flores-Flores has shown great promise as a young investigator and has experience conducting research in
the epidemiology of aging and chronic diseases in low- and middle-income countries (LMICs). However, he is
now proposing to gain expertise in implementation science and requires additional training and mentorship to
do so. His overall career goal is to become an independent investigator in the implementation of evidence-
based mental health care interventions for older adults, and this award will provide Dr. Flores-Flores with the
support and training to accomplish this goal. He has assembled an experienced mentorship team including:
Dr. Jose Parodi [Primary LMIC Mentor, geriatrics & public health, Associate Professor (USMP)]; Prof. Joseph
Gallo [Primary U.S Mentor, mixed methods research, Professor (JHSPH)]; Prof. Marina Piazza [Co- Mentor,
Implementation Science, Professor (UPCH)]; and Dr. William Checkley [Co-Mentor, hybrid effectiveness-
implementation study Designs, Associate Professor (JHSPH)]. Through a combination of close mentorship,
practical experience and key coursework, Dr. Flores-Flores proposes to accomplish the following training
goals: 1) training in implementation science; 2) training in experimental study designs; and 3) advanced
training in mixed-methods research; 2)
Depression and anxiety symptoms are highly prevalent in older adults, and often present together.
Evidence-based care exists to reduce depression and anxiety symptoms in older age. Trans-diagnostic
approaches such as problem-solving therapy (PST) have been shown to be effective and have been
recommended by the World Health Organization (WHO). However, there are myriad barriers to accessing
mental health care in older adults. Thus, interventions that systematically and effectively target those barriers
are urgently needed. Dr. Flores-Flores proposes to adapt, test, and refine a multi-faceted intervention strategy
to deliver mental health care to older adults in low resource settings in Lima, Peru. He proposed to determine
whether delivering mental health care via community health workers will have high uptake and will improve
symptoms of depression and anxiety in older adults. Results from this study will generate preliminary data to
compete for an R01-level award to conduct a large cluster implementation-effectiveness trial in multiple
communities and determine the effect of the intervention on depressive/anxiety symptoms and other health-
related outcomes.

Public health relevance
PROJECT NARRATIVE Depression and anxiety in old age are often neglected and poorly treated. The wide gap in mental health care among older adults can be tackled by delivering context-appropriate intervention strategies. The long-term goal of this proposal goal is substantially reducing the burden of these common mental conditions.